The National Longitudinal Mortality Study (NLMS)

The purpose of this Interagency Agreement (IAA) is to authorize the transfer of funds appropriated for the Surveillance Research Program (SRP) of the Division of Cancer Control and Population Sciences (DCCPS), National Cancer Institute (NCI) to the U.S. Census Bureau to facilitate the access of extramural investigators to the linked NLMS resource.